An experimentally-refined, dynamic gene regulatory network model of T-cell memory

An experimentally-refined, dynamic gene regulatory network model of T-cell memory
Summary
T cell memory induced by prior exposure to a pathogen or vaccination provides enhanced protection against a
subsequent infection with the same pathogen. Enhanced protection is partially driven by clonal expansion, which
leads to an increased number of T cells capable of recognizing the antigen. Additionally, memory T cells possess
a “rapid recall ability” that allows them to fight pathogens by producing cytokines and other effector molecules
within minutes of re-exposure (as opposed to days, upon initial exposure). We recently showed that rapid recall
correlates with the epigenetic poising of enhancers and promoters of the “rapid-recall genes” in memory T cells.
Importantly, the sites of epigenetic change significantly overlap with the risk loci for autoimmune and atopic
disease, suggesting that this mechanism is important for human health. However, it is still unclear if and how
the epigenetic poising causes enhanced expression of rapid recall genes. Furthermore, memory T cells persist for
a lifetime; yet the mechanisms that maintain the memory epigenome – for decades– are not known. Our
preliminary data suggest that rapid recall is coordinated by several families of transcription factors (TFs) and
thousands of putative DNA regulatory elements. This complexity requires a systems-level, engineering approach.
Thus, this proposal is a collaboration between the groups of Artem Barski, a T cell biologist, and Emily Miraldi,
a mathematical modeler, to create experimentally validated, genome-scale models of memory immune responses
across heterogeneous T cell populations.
Aim 1. Using single-cell genomics, we will characterize the gene expression and chromatin dynamics of T cell
activation in naïve and memory cells and build mathematical models that integrate these data (along with
relevant existing genomics resources) into a dynamic gene regulatory network (GRN). Our GRN model will
predict the molecular drivers (TFs) and regulatory elements that orchestrate rapid recall.
Aim 2. Although T-cell activation in naïve and memory cells similarly promotes nuclear translocation of
inducible TFs, our data lead us to hypothesize that chromatin remodeling upon initial pathogen exposure alters
the occupancy of inducible TFs in memory T cells and that this is the basis of rapid recall. We will combine
dynamic TF perturbation and occupancy experiments to establish the molecular interactions driving rapid recall.
Aim 3. We will identify the mechanisms by which memory T cells maintain the epigenome conducive for
rapid recall – over the human lifespan. We hypothesize that constitutive TFs maintain the epigenome poised for
rapid recall. We propose dynamic TF perturbation experiments to uncover the identities of these regulators.
This study will help uncover basic mechanisms of T cell memory and identify potential targets for
manipulating immunologic memory responses. Because rapid recall is the basis for vaccination and central to
allergy, asthma, and cancer immunity, this study will have a broad impact on human health.

Public health relevance
Narrative Immune-cell memory induced by prior exposure to a pathogen or vaccination provides enhanced protection against a subsequent infection with the same pathogen; yet the molecular mechanisms by which immune cells “remember” previous exposures – over the course of a lifetime – are poorly understood. Here, we combine experimental measurement with mathematical modeling to uncover the epigenetic mechanisms by which immune-cell memory is maintained. The resulting models will provide new insights of value to human health, as immunological memory not only underlies pathogen defense but is dysregulated in many diseases, including autoimmune, allergy and cancer.